Administration and Evaluation Core

The purpose of the Administration and Evaluation Core is to bring together the requisite personnel and resources to ensure that the goals of the Delaware INBRE(DE-INBRE) proposal are achieved effectively. The Administration and Evaluation Core consists of a central leadership team comprised of the DE-INBRE PD/PI and PC with appropriate administrative support, internal and external advisory and evaluation components, an internal Research Committee with an expanded mentoring focus, and a Steering Committee comprised of high-level leaden; at the DE-INBRE partner institutions.